Minnesota Tissue Mapping Center for Senescent Cells

Project Summary 2024: Benchmarking Project
The SenNet consortium is working together to develop and apply multiple spatial imaging technologies to
investigate the molecular and cellular heterogeneity of cellular senescence in aged tissues. However, one major
obstacle faced by the consortium is the uncertainty surrounding the ability of the various technologies being
employed to robustly characterize senescent cells in different tissues. To address this challenge, the SenNet
consortium will undertake a collaborative effort to test the effectiveness of various spatial omics technologies on
the same human tissue across different sites, as well as to test their effectiveness across different tissues. This
endeavor aims to accomplish several goals: firstly, to determine the robustness of senescence-associated
marker detection based on the platform, secondly, to extract diverse information about senescence from the
same tissue. This consortium-wide benchmarking project will focus on spatial omics techniques that offer single-
cell resolution. This approach is based on the current understanding that senescent cells are present in relatively
low abundance in aged tissues and the need to use technologies that can accurately detect individual senescent
cells and differentiate them from surrounding cells. By rigorously testing the robustness of high-plex technologies
already in use within the SenNet Consortium across multiple sites and tissues, we will determine which
techniques are most accurate and informative in detecting senescent cells in different tissues.

Public health relevance
Project Narrative The purpose of the Supplement is to further the scientific goals of the Cellular Senescence Network (SenNet) of enabling rigorous and reproducible detection and spatial localization of senescent cells in human tissues by: 1. comparing the performance of spatial transcriptomics and proteomics techniques on the same tissue, 2. comparing the reproducibility across sites; 3. compare the performance of the same spatialomics platforms on different tissues, and 4. expanding the number of different tissues studied in the Cross-Consortium Benchmarking Project.